Parp Function in Prostate Cancer

PROJECT SUMMARY
This proposal builds upon our discovery in the previous funding period of a novel pathway in
prostate cancer cells that integrates androgen signaling with ADP-ribosylation. The pathway has
four key components, the androgen receptor (AR), Parp7, Parp9 and Dtx3L. We found that the
pathway involves AR induction of Parp7 and multi-site mono-ADP-ribosylation by Parp7, on
cysteines in the AR amino-terminal domain. In this pathway, Parp7 acts as an ADP-ribose writer
and Parp9 serves as an ADP-ribose reader, and the outcome of these reactions is androgen-
dependent assembly of an AR-Dtx3L/Parp9 complex and regulation of AR activity as a
transcription factor. With this knowledge base, we are positioned to tackle important questions
on how the pathway drives biological effects in prostate cancer cells, and whether Parp7 is an
actionable target in models that include castrate-resistant prostate cancer where there is an
unmet clinical need. In Aim 1, we will determine how the AR-Parp7 pathway and mono-ADP-
ribosylation regulate tumorigenesis in prostate cancer cells using structure-function experiments
that interrogate the contributions of each of the four components. Since AR is the only known
Parp7 substrate in prostate cancer cells, we will define the ADP-ribosyl-proteome in prostate
cancer cells to identify additional, AR-independent pathways, by which Parp7 regulates prostate
cancer cells. In Aim 2 we will determine the molecular basis for ADP-ribose writing and reading
on the AR-Parp7 pathway. Parp7 ADP-ribosylation of AR is specific for androgen-bound AR,
and we have a strategy in place to determine how the agonist conformation of AR generates
sites that are permissive for ADP-ribosylation. AR will be used as a model to study the reader
function of Parp9 macrodomains, in particular, the features that are important for selectivity. In
Aim 3 we determine the vulnerability of prostate cancer cells to a first-in-class Parp7 inhibitor,
and test whether the inhibitor can prostate growth and metastasis. Our study will benefit from
significant contributions from a team of national and international scientists with expertise in
prostate cancer models, proteome-scale mass spectrometry, synthetic peptide chemistry, Parp
structural biology, and implementation of Parp inhibitors. Our overall hypothesis is that
androgen signaling transduced through Parp7 regulates both genomic and non-genomic
pathways, and that selective blockade of Parp7 will inhibit prostate tumorigenesis. If the
hypothesis is correct, our work will identify Parp7 as a new therapeutic target in prostate cancer
and expand the toolbox of Parp inhibitor-based treatments.

Public health relevance
PROJECT NARRATIVE Prostate cancer remains the second leading cause of deaths due to cancer in North American men. Defining the communication pathways that operate within prostate cancer cells, which is to say, how proteins talk to each other, reveals vulnerabilities that can be exploited therapeutically. We discovered a communication pathway in prostate cancer cells, and propose to determine how it works, and if pathway inhibition with a new drug (in clinical trials) can kill prostate cancer cells.